Administrative Core

The goal of the Administrative Core is to provide budgetary and administrative support to the other 4 cores and
4 projects in the Diabetes Prevention Program Outcomes Study (DPPOS) Alzheimer’s Disease (AD)/AD related
dementias (ADRD) Project. The Administrative Core will support the governance structure of the DPPOS
AD/ADRD Project, and will interact with leadership at the National Institute on Aging (NIA) and other national AD
and ADRD research and research education programs. The DPPOS has a well-developed organization that has
conducted ground-breaking research in pre-diabetes (preD) and type 2 diabetes (T2D) over more than 25 years,
supporting 25 clinical sites and multiple reading centers across the United States. The success of this
organization is best reflected by the high level of retention of clinical centers and participants; assiduous
adherence to the study protocol; hundreds of publications in high impact journals; and the development of T2D
prevention guidelines and programs based on DPPOS findings that have been adopted widely, including by the
Center for Medicaid and Medicare Services. The DPPOS working committees and subcommittees will remain
largely intact, with the AD/ADRD Project’s Executive Committee, Steering committee, Publications and
Presentations Committee, and Ancillary Studies Committee continuing into the proposed funding period under
the Administrative Core. The leadership of the Administrative Core will be the same as for the overall project
using a multiple principal investigator (PI) arrangement, shared by PIs Luchsinger, Nathan, and Temprosa. PI
Nathan has been the chair of the DPPOS since its inception. PI Temprosa has been the leader of the DPPOS
coordinating center based at George Washington University. Contact PI Luchsinger has led the Cognitive
Coordinating Center of DPPOS since 2009, has co-led its Working Group on Aging, and has led NIA funded
AD/ADRD research and education programs for 20 years. The Administrative Core (AC) will achieve its goals
through the following specific aims: (1). Support the governance structure of the proposed U19; (2) Support all
cores and projects logistically and financially; (3) Ensure administrative and regulatory compliance; (4) Support
dissemination and collaboration; (5) Support mentorship and career development in T2D and AD/ADRD
research; (6) To evaluate the success of the proposed research program through measurable goals and
outcomes.